Genome Characterization Unit

The GCU will provide comprehensive, end-to-end CLIA-compliant genomic testing and cuttingedge research-level analysis of patients with multiple myeloma (MM), colorectal cancer (CRC),
and cholangiocarcinoma (CHOL). This testing will be conducted on diagnostic tumor samples and
matched normal tissue from patients for each of the three cancer types during the WU PE-CGS
research program. Sample processing by the GCU will include nucleic acid extraction and QC.
Diagnostic samples will be analyzed using 250X tumor/normal exome sequencing (WES) with
both somatic and germline analysis for gene-level single-nucleotide variants (SNVs) and
insertion/deletions. Tumor-only WGS (60X) will be performed to detect tumor-associated
structural mutations, and tumor RNA-seq will support, confirm, and extend findings from the DNAbased assays. Tumor tissue and/or cell-free DNA will also be analyzed with targeted deep
sequencing (>10,000X) using unique molecular indexes (UMI) for sensitive detection and
monitoring of tumor-associated mutations. All assays will be performed using CLIA-compliant
procedures with integrated quality management practices. The GCU will also conduct researchlevel scRNA-Seq, proteomics, and cellular imaging studies on selected samples to enhance our
understanding of these tumor types. Genomic assays will proceed according to a planned
schedule for year-by-year combinations of diagnostic specimens and follow-up collections, with
small numbers of candidates selected for research studies. Results from these assays will be
returned to participants using a tiered reporting process based on participant preference. Tier 1
results will highlight findings with established clinical relevance obtained from CLIA sequencing of
individual participants, including pathogenic, tumor-associated somatic drivers and inherited
mutations that are clinically actionable according to published guidelines and that will be reported
using established categorization for somatic drivers and pathogenic germline variants, their
clinical implications, and possible actions. Participants can elect to receive Tier 2 results, which
will be comprised of additional mutations from the same CLIA-compliant data identified with
advanced methods and are predicted to be clinically relevant via functional annotation, as well as
results from targeted sequencing of follow-up samples for monitoring tumor evolution over time.
Research-level Tier 3 molecular studies may also be provided to participants as aggregate, deidentified reports that can be used to enhance and extend interpretations of their individualized
CLIA results. These results will also be sec